Goals for Adherence with Low-cost Incentives (GOALS)

Project Summary
Treatment outcomes of HIV-positive youth in Uganda and elsewhere are threatened by low medication
adherence. Despite the clear need for adherence support among youth, few interventions target this
particularly vulnerable group during a time of heightened risk-taking behavior and unfinished development of
cognitive control processes such as planning and goal-directed behavior. Incentives informed by behavioral
economics (BE) have successfully changed a range of health behaviors by countering present bias (the
tendency of overly discounting the future benefits of preventive health behaviors) including our own study that
improved ART adherence. However, they have rarely been tested among youth living with HIV (YLWH) who
are likely to particularly benefit from such extrinsic rewards given their observed problems with self-control.
Traditional incentives that require individuals to reach a uniform, high eligible threshold by design leave out
those unable to meet it, often most in need of support. In a pilot study, we tested a novel incentive design that
allowed even those with low initial adherence to qualify for incentives, resulting in their improved adherence.
BE theory suggests that the effort exerted to reach a goal depends on how far away it is from the participant; if
the goal is within close reach, the participant shows great willingness to achieve it, but if the goal is set too
high, s/he becomes demotivated and may give up. Based on this insight, we restructured our incentive design
to allow participants to set their own eligibility threshold. We propose to build on our pilot results using a
randomized controlled trial (RCT) to establish effectiveness. Our intervention, GOALS, proposes testing
externally assigned sub-goals gradually increasing towards 90% (T1, n=140) and self-chosen, participatory
interim goals (T2, n=140), against a traditional, fixed goal of 90% (T3, n=140). The control group (n=140) will
receive the usual standard of care. The primary outcome is electronically measured ART adherence collected
throughout the study and for 12 months after incentives are withdrawn to measure the persistence of behavior
change; suppressed viral load will be the secondary outcome. The Specific Aims in year 1 (Improvement
Phase) is to evaluate the relative effectiveness of the three incentivization approaches for improving adherence
among YLWH. In year 2 (Maintenance Phase), we test the relative effectiveness of the three ways of
incentivization for maintaining adherence. In year 3 (Persistence Phase) the goal is to investigate for 12
months the relative effectiveness of the three GOALS intervention arms at creating behavioral persistence
once incentives are removed. Specific Aim 4 is to perform a cost-effectiveness analysis including a
comparative analysis of those GOALS intervention arms that show a positive intervention impact for improving
and/or maintaining adherence.

Public health relevance
Project Narrative There is a paucity of support for young people living with HIV (YLWH) who often fail to achieve viral suppression, with catastrophic consequences in particular in resource-constrained countries in which treatment options are limited. This study aims to improve ART adherence among YLWH by providing small incentives based on insights from behavioral economics, combined with text messages sent by mobile phone. The approach is particularly targeted at those with low adherence as it allows to adjust eligibility thresholds for incentives to participants’ initial adherence, thereby reducing health inequality and facilitating high, long-term ART adherence for a particularly vulnerable group of HIV clients.